Elucidating the Role of the Rnf20 Histone Modifier in Pancreatic Beta Cell Function and Senescence

PROJECT SUMMARY
Diabetes is characterized by the loss of functional pancreatic β-cell mass. With the prevalence of diabetes
increasing across the globe, it is crucial that we develop a complete understanding of the gene regulatory
mechanisms governing the maintenance of insulin-producing β-cell identity and function. In our previous work,
we demonstrated that the Isl1 transcription factor and its histone-modifying co-regulators Rnf20 and Rnf40 are
crucial for β-cell gene expression. Recently, we observed that in mice, β-cell-specific loss of Rnf20 (Rnf20Δβ-cell)
prompts a disruption of glucose homeostasis, loss of β-cell identity gene expression, and an upregulation of cell
cycle inhibitor mRNA, p19Arf. In aging human and mouse β-cells, cell cycle inhibitors encoded by Cdkn2a,
p19Arf and p16Ink4a, are upregulated and impart a reduction in functional capacity known as senescence. While
suppression of the age-associated upregulation in Cdkn2a expression is known to reverse β-cell senescence,
the transcriptional mechanisms that repress Cdkn2a in healthy β-cells are understudied. In this proposal, I will
investigate the regulatory relationship between Rnf20 and Cdkn2a to assess whether Rnf20 mediates β-cell
senescence. My primary hypothesis is that Rnf20 protects against senescence-associated loss of β-cell
functional identity through direct regulation of the Cdkn2a locus. I will address this hypothesis with two aims. In
Aim 1, I will evaluate how the β-cell specific loss of Rnf20 affects the β-cell cycle and the appearance of the
senescence-associated secretory phenotype. I will also perform systemic senolytic treatment to determine if
targeted elimination of senescent cells rescues the glucose intolerance and reduced plasma insulin levels that
occur in Rnf20Δβ-cell mice. In Aim 2, I will determine whether Rnf20 regulates the transcription of Cdkn2a. I will
perform Chromatin Immunoprecipitation (ChIP) to assess if Rnf20 directly occupies the Cdkn2a promoter and
ATAC-seq to see if loss of Rnf20 increases Cdkn2a chromatin accessibility. Our results will increase
understanding of the transcriptional mechanisms regulating both the maintenance of β-cell identity and the
process of β-cell senescence. Additionally, our outcomes may be used to inform future diabetes therapies
through either the incorporation of Rnf20 into either β-cell differentiation protocols or as a biomarker for β-cell
health. Furthermore, the proposed research plan provides a balanced training platform wherein I will expand
both my critical thinking and technical skillset through my investigations of novel regulatory mechanisms of β-
cell homeostasis. As a trainee at the University of Alabama at Birmingham (UAB) and in UAB’s Diabetes
Research Center, I have access to a strong community of supportive faculty members to assist in the successful
completion of the proposed study. Taken together, this research and training plan is a fundamental catalyst of
my trajectory toward becoming an independent research scientist.

Public health relevance
PROJECT NARRATIVE Across the globe, 537 million individuals are diagnosed with diabetes and in the United States, the prevalence has steadily increased from 2001 to 2020. This project aims to study the gene regulatory mechanisms of β-cell identity, function, and senescence mediated by the epigenetic regulator, Rnf20, with the overall goal of identifying factors involved in the maintenance of healthy insulin-producing β-cells. Our findings will provide a better understanding of the factors and pathways that maintain β-cell function, which is crucial for the development of novel diabetes therapies that can mitigate comorbidities associated with diabetes.